Diabetes Models Phenotyping

PROJECT SUMMARY: Diabetes Models Phenotyping Core
The Diabetes Models Phenotyping (DMP) Core is an important component of the Washington
University Diabetes Research Center (DRC). The long-term goal of the DMP Core is to enhance diabetes-
related research at Washington University using sophisticated services and technologies with the potential to
contribute to discoveries that can be translated to novel treatments for diabetes and related disorders. The
DMP Core has three objectives: 1) To provide phenotyping services to DRC members to both facilitate
and enhance the cost-effectiveness of NIH-funded diabetes/metabolism-related research; 2) To provide
expert consultation and training to DRC members in experimental design and characterization of
mouse models relevant to diabetes, obesity and associated metabolic diseases; and 3) To develop new
research capabilities to enhance the ability of DRC members to perform diabetes and metabolic
research. The Core offers a broad range of animal phenotyping services, including a) body composition
analysis using EchoMRI and/or DEXA scan; b) indirect calorimetry to measure energy expenditure; c) glucose
and insulin tolerance testing; d) blood pressure determinations; and e) biochemical analyses of serum and
tissues to measure glucose, triglycerides, free fatty acids and cholesterol. Meeting a key need in the diabetes
research community at Washington University, the Core provided services to 44 different DRC member
laboratories during the past funding period, including 11 P&F recipients. The services utilized by these
investigators over this time frame include biochemical assays of serum (>4,800 samples) and tissues (>1,100
samples), body composition determinations for >8500 mice, and indirect calorimetry assessments in >2,400
mice, to mention the services in greatest demand. These analyses supported the publication of 130 papers.
The Core continually evolves in response to user needs through elimination of some services and addition of
others. New and expanded services include hyperinsulinemic-euglycemic clamps, thermogenic phenotyping,
and expanded training and consultation. Together, DMP Core services continue to help DRC investigators
contribute important scholarly advances with substantial potential for translation to improved care for patients
suffering from diabetes and related complications.